LABORATORY SUPPORT CORE

The Laboratory Support Core provides the basic support for several centralized services and core facilities that are used by the research groups in the Program, including media preparation services, a central glassware facility, shared heavy equipment, and the x-ray film processor. In addition, this core provides partial support for centralized microarray and robotics facilities, which are heavily used by program members.